ZUNI KIDNEY PROJECT STUDY I--POPULATION BASED SURVEY OF RENAL DISEASE

This study explores the hypothesis that there are genetic environmental interactions that modulate the risk for kidney disease at Zuni. The first part of this project is to conduct a population-based, cross-sectional survey of the entire Zuni population over 5 years of age.